Design and optimization of TCR-T therapeutics by an advanced T cell receptor-antigen binding prediction platform

Abstract
Nightstar Biotechnologies has developed an Artificial Intelligence (AI) platform for therapeutic T-cell receptor
(TCR) design to aid in the design of novel therapeutic TCR-T cells for cholanigiocarcinoma (CCA) treatment.
Emerging biotherapies, such as TCR-T therapy, create a new avenue for T-cell-based biotherapeutics. While
CAR-T cells are limited to targeting TAAs expressed on the cell surface, TCR-T cells allow for a larger repertoire
of TAA targets including intracellular oncogenes. By exploiting the intrinsic features of TCRs, T-cells can be
engineered with much higher sensitivity to improve both cytotoxicity and therapeutic T-cell persistence.
Traditional experimental design methods for TCRs generally rely on TAAs that are highly expressed; however,
design of TCRs allows targeting of TAAs with low expression levels, thereby promoting higher specificity and
therapeutic efficacy. This design tactic is currently beyond the reach of the traditional approaches. The ability to
flexibly increase or decrease the binding affinity of TCRs against multiple antigens is critical to (a) achieve
detection and targeting of minimally expressed tumor antigens, while (b) avoiding off-target, off-tumor toxicities
from recognition of non-specific antigen recognition. NightStar Biotechnologies has developed an AI foundation
model, pMTnet, for predicting the interactions between TCRs and T-cell antigens (pMHCs) for designing optimal
therapeutic TCRs and aid in the design of successful therapeutic TCR-T cells. The pMTnet platform can address
these difficulties and dramatically narrow down the scope of required experimental validations to ultimately yield
in better, faster, and cheaper design of TCR-T therapies to benefit cancer patients and those diagnosed with
autoimmune disorders. As proof-of-concept for AI-assisted design and optimization of TCR-T cells, NightStar
Biotechnologies intends to use their pMTnet model to optimize a TPX2-TCR-T cell as a new immunobiologic
therapy for CCA. CCA is a rare, heterogenous cancer of the hepatobiliary tract that affects around 8,000 people
a year with a five-year survival rate of only 9%. Approximately 75% of CCA patients are diagnosed at late stages
with locally advanced or metastatic disease, resulting in very few patients that qualify for the only effective
therapy: surgical resection. Expression of targeting protein for Xklp2 (TPX2) is associated with advancing CCA
disease and is linked to aberrant cell proliferation, promotion of DNA damage repair, as well as migration and
invasion in CCA. In this proposal, Nighstar Biosciences will (1) Identify high affinity TCR sequences against
TPX2, (2) evaluate the functional ability of the TPX2-TCR-T cells against CCA cell lines in vitro, and then, (3)
validate the anti-tumor efficacy of the lead TPX2-TCR-T candidate using mouse models engrafted with CCA
patient-derived xenografts. Upon completion of this proposal, Nightstar Biotechnologies will have shown proof-
of-concept for their pMTnet TCR discovery platform to develop therapeutic TCRs, as well as characterized the
feasibility of a TPX2-targeted TCR-T therapy for CCA, providing a hopeful strategy for patients diagnosed with
this disease.

Public health relevance
Narrative The use of artificial T-cell receptors (TCRs) for more sensitive and specific T-cell therapeutics is a currently emerging process for the next generation of immunobiologics; however, given the complexity of TCR interactions with multiple antigens and various affinities, determining optimal TCR structure is laborious and time-consuming. Nighstart Biotechnologies has developed a comprehensive artificial intelligence (AI)-based TCR design platform, pMTnet, to efficiently identify optimal TCRs with the ability to fine-tune TCR affinity to detect tumor associated antigens and limit off-target binding.